Mechanisms Behind Retinal Photoreceptor Cells Outer Segment Biogenesis

PROJECT SUMMARY/ABSTRACT
The long-term goal of our study is to decipher the mechanisms controlling the morphogenesis of the
photoreceptor outer segment (OS), a cellular compartment vital for our vision. This proposal will specifically
investigate the role of “Progressive Rod Cone Degeneration” (PRCD), in photoreceptor function and OS
biogenesis. PRCD is exclusively present in photoreceptor OS disc membranes and associates with
rhodopsin. The proposed studies are also clinically relevant as mutations in PRCD cause retinitis
pigmentosa (RP) in humans and dogs. Our recent study showed that PRCD is post-translationally lipid
modified by “palmitoylation” in a sole cysteine (Cys2), which is linked with RP in humans and dogs
(Cys2Tyr). Despite the importance of PRCD in retinal function, the role for PRCD in photoreceptors is not
known and is the main focus of this application. The first aim of this study will investigate the role of PRCD
in photoreceptors using a novel PRCD-KO animal model generated by CRISP-Cas9 genome editing. The
second aim will determine how the common patient mutation (C2Y) in PRCD leads to retinitis pigmentosa
(RP) using multiple transgenic animal models. Our proposed studies are aligned with the Retinal Diseases
Program of the NEI to “Identify the genes involved in both inherited and retinal degenerative diseases
(including RP), determine the pathophysiological mechanisms underlying PRCD mutations, and determine
new potential therapeutic strategies for treatment such as gene transfer, tissue and cell transplantation,
growth factor therapy, and pharmacological intervention.

Public health relevance
PROJECT NARRATIVE The studies proposed in this application will address the mechanism(s) behind photoreceptor cell outer segment biogenesis. This research study will significantly advance our understanding of the maintenance of OS, and how the discs are shaped, stacked and organized. We strongly believe that these studies have a strong potential to reveal an important “missing link” where the photoreceptor outer segment architecture is maintained, and which will significantly advance the knowledge in the field of photoreceptor cell biology.